Distinct Glycophenotypes with Abnormal Signaling Define a Subpopulation of B cells Responsible for Production of Galactose-Deficient IgA1, the Main Autoantigen in IgA Nephropathy

Project Summary
IgA nephropathy (IgAN) is the most common primary glomerulonephritis in the world, with 30-50% of patients
progressing to end-stage kidney disease. Diagnosis is biopsy-based, with routine immunofluorescence
showing IgA (co)dominant immunodeposits usually with C3 and often with IgG co-deposits. IgA in the
immunodeposits is of IgA1 subclass and enriched for galactose-deficient IgA1 glycoforms (Gd-IgA1). There is
currently no disease specific therapy for IgAN due to our limited understanding of the underlying mechanisms
of disease progression. Recent data indicate that IgG is present in immunodeposits of virtually all IgAN
patients and that it is enriched for Gd-IgA1-specific autoantibodies. Furthermore, Gd-IgA1 and anti-Gd-IgA1
IgG autoantibodies are elevated in the circulation of IgAN patients and their levels predict disease progression.
Based on these, and other data, we have proposed a multi-hit hypothesis explaining the autoimmune nature of
IgAN: Gd-IgA1 is elevated in circulation of IgAN patients and is recognized by anti-Gd-IgA1 IgG
autoantibodies, resulting in the formation of circulating immune complexes, some of which deposit in the
glomeruli, inciting renal injury. The origin of the autoantigen and the characteristics of specific cell population(s)
producing Gd-IgA1 remain unknown. Recently, we showed that immortalized IgA1-secreting cells from IgAN
patients produce more Gd-IgA1 autoantigen compared to the cells from healthy controls. Furthermore, only
these IgAN-derived cells increase Gd-IgA1 production in response to cytokine stimulation (e.g., IL-6). Follow
up analysis found enhanced STAT3 and STAT1 activation only in IgAN B cells, and that it was necessary for
Gd-IgA1 production following cytokine stimulation. Single-cell transcriptome analysis of cytokine stimulated B
cells from IgAN patients found IgHA1-subpopulations with abnormal expression of genes responsible for
regulation of multiple cytokine signaling pathways. These IgHA1-subpopulations also exhibited abnormal
alterations in the expression level of glycosyltransferase enzymes relevant to IgA1 glycosylation.
Transcriptional data alone does not identify Gd-IgA1 producers. To address this, we developed a novel
glycophenotyping method using lectins and recombinant anti-Gd-IgA1 IgG that can target cell surface
presentation of Gd-IgA1. This process enriched for low and high Gd-IgA1-producing subpopulations, which had
differential activation of transcriptional factors before and after cytokine stimulation. Using this
glycophenotyping method with nucleotide conjugation, we can target Gd-IgA1-producing cells for transcriptome
analysis, intracellular signaling staining, chromatin remodeling, and specific autoantigen production rates.
Together, these studies will elucidate the mechanisms of autoantigen production within specific subpopulations
of IgA1-producing cells and potentially lead to the development of new disease therapies for IgAN.

Public health relevance
Project Narrative IgA nephropathy, the most common primary glomerulonephritis in the world, often resulting in end-stage kidney disease with no disease specific treatment. Although it is known to be an autoimmune disease, the mechanisms that underlie the production of the critical autoantigen that mediates disease progression are unknown. The proposed studies will integrate single-cell RNA analysis with a novel cell-surface glycophenotyping to analyze the specific immune cell populations responsible for autoantigen production.